Admin Core: integrating innovative genomic science for infectious disease

The goal of this proposal is to address NIAID’s mission through continued implementation of a Genomic Center
for Infectious Diseases, a collaborative program utilizing cutting-edge genomic technologies, including
laboratory-based methods, bioinformatics processes and computational analyses. To ensure we achieve this,
we have established an Administrative (Admin) Core with proven expertise managing a large-scale genomics
program to combat a variety of existing and emerging infectious diseases, with the power and flexibility to
support national and global public health priorities. The Administrative Core will be responsible for establishing,
monitoring and reporting on individual Research Projects and Cores, as well as for budgetary oversight, and
ensure progress across the entire center. The Admin Core will manage priorities, timelines and milestones, and
ensure rapid public data release and dissemination of resources, including implementation of our Data
Management and Sharing Plan. The Admin Core will manage our interactions with NIAID staff and other
activities needed to maintain efficient and cooperative work among multiple centers. The Admin Core will
manage and report on our Emergency Response Project Plan, our Plan for Enhancing Diverse Perspectives
and educational outreach activities, and our Collaborative Pilot Projects and other work within the network of
GCIDs. Our Admin Core leadership, including PIs Neafsey and Birren, has extensive experience managing
highly collaborative research, technology development, dissemination, and training in service of the wider
infectious disease community and public health, and the variety of complex interactions that underlie these.
The Specific Aims of this Core are as follows:
Aim 1. Establish a Leadership Team, Organizational Structure and Management Practices to support a leading
Genomics Center for Infectious Diseases. Our leadership and management plan will employ best practices
from industry to establish clear goals and manage the center and its resources toward these goals.
Aim 2. Establish an Outreach Program to ensure our center incorporates diverse perspectives and broadens
participation in infectious disease research by training members of underrepresented and marginalized
communities to use the methods, approaches and resources of the Center.
Aim 3. Organize and manage activities to enable rapid emergency responses to outbreaks and epidemics as
well as synergistic, collaborative interactions among GCIDs.
By establishing and actively managing the proper metrics for all aspects of our performance, and
utilizing professional management practices to maintain effective communication, relentlessly improve our
processes and continually draw in diverse perspectives, the Admin Core will ensure we meet our initial goals
and that we remain responsive to arising needs in serving NIAID’s mission combating infectious disease.